Investigating how the conserved ZNFX-1 protein regulates epigenetic inheritance and germline immortality in Caenorhabditis elegans

Project Summary
Germ cell immortality is essential for fertility and for species survival. To proliferate indefinitely, germ cells depend
on mechanisms that maintain genome integrity and epigenetic programs. In animals, small RNAs that interact
with Argonaute proteins of the PIWI family—called piRNAs—serve as a vanguard of transcriptome and
epigenome integrity in the germline, by identifying and silencing transposable elements and by regulating
germline gene expression. In many animals, piRNAs are essential for germline health. Defective piRNA
biogenesis or function activates transposon expression and mobility, increases DNA damage, disrupts germ cell
development, and reduces fertility.
In Caenorhabditis elegans, small RNA pathways with opposing activities collaborate to maintain germ cell
survival and fertility. Recent studies identified ZNFX-1 as a regulator of epigenetic inheritance in worms. ZNFX-
1 is a highly conserved UPF1-like helicase with C-terminal NF-X1-type zinc finger domains. znfx-1 mutants
activate epigenetically silenced reporters, and in some cases they silence normally active reporters, indicating
that ZNFX-1 balances opposing epigenetic programs. The targeting pattern of small RNAs redistributes in znfx-
1 mutants, suggesting that ZNFX-1 determines the origin of small RNAs required for silencing and anti-silencing
pathways. Preliminary data also show that znfx-1 null mutations cause a mortal germline phenotype at elevated
temperatures, suggesting that ZNFX-1 maintains balanced epigenetic signals essential for germline immortality.
This proposal seeks to use genetic, computational, and biochemical approaches to test the hypothesis that
ZNFX-1 is recruited to targets and identifies sites of small RNA biogenesis. Studies in Aim 1 will determine how
ZNFX-1 regulates small RNA biogenesis by identifying how and where it binds to target transcripts, and if it
unwinds or moves along RNA. Studies in Aim 2 will determine how ZNFX-1 regulates germline immortality by
identifying functional domains of ZNFX-1, potentially redundant proteins with homologous domains, and small
RNA and transcriptome features of germline immortality. These studies will reveal how animals transmit heritable
epigenetic information and how epigenetic pathways maintain germ cell immortality. In addition, the proposed
research will provide training in genetics and epigenetics, quantitative biochemistry, and computational
approaches, and prepare the fellow for a postdoc in computational and systems biology and a future career as
an independent investigator.

Public health relevance
Project Narrative Germ cells must remain immortal for species survival. This study seeks to reveal how small RNAs control germ cell immortality.